Administrative Supplement for Peptide Synthesizer

The COBRE Center for Targeted Therapeutics (CTT) at the University of South Carolina (UofSC)
supports research that seeks to develop new and more effective classes of drugs against various
diseases, by aiming these drugs at molecular and cellular targets that play a key role in the
disease. The Drug design and Synthesis Core provides access to synthetic chemistry and
structure-based drug design resources, and these are a critical part of the drug discovery process.
Many of the projects being pursued involve the targeting of protein-protein interactions and part
of the target validation approach is to identify peptide ligands that represent starting points for
application of strategies can convert these into more drug-like compounds. Another approach to
drug discovery is the solid phase synthesis of DNA encoded chemical libraries which combined
with the mix and split library approaches would allow significant chemical diversity to be
generated. We seek to acquire a state-of-the-art solid phase synthesizer which can be used to
generate libraries of peptides, peptidomimetics and other fragment-oriented compounds rapidly
and efficiently through parallel synthesis. This will substantially increase the capabilities of the
DDSC in early-stage drug discovery and support multiple projects currently underway or planned
for the near future.

Public health relevance
The COBRE Center for Targeted Therapeutics (CTT) at the University of South Carolina (UofSC) supports research that seeks to develop new and more effective classes of drugs against various diseases, by aiming these drugs at molecular and cellular targets that play a key role in the disease. This application is for an administrative supplement to fund the acquisition of a state-of- the-art solid phase synthesizer which can be used to generate libraries of peptides and other fragment-oriented compounds thus increasing the capabilities of the DDSC in early-stage drug discovery.